T Cell Alloreactivity and Organ Transplant Risk Stratification Models Using High-Resolution HLA and Genomic Data

The conventional focus for histocompatibility in clinical solid organ transplantation focuses on humeral immunity,
avoiding donor HLA molecules against which the recipient has pre-existing alloantibodies capable of mediating
hyperacute rejection. While this is a practical approach mitigating some immunologic risk based on clinically available
information, it does not address the inherent risks of T cell alloreactivity, which is a significant
contributor to allograft rejection and requires life-long immunosuppression. In this proposal, we will leverage
sequencing technologies and approaches adapted from immune-oncology to identify HLA allele-specific factors
in solid organ transplant donors and recipients driving T cell alloimmune responses. We will develop a
computational algorithm, CHART, to predict donor/recipient pair-specific T cell alloreactivity and risk of solid
organ transplant rejection, with the goal toward precision medicine approaches for histocompatibility and
personalized immunosuppression.

Public health relevance
Project Summary The conventional focus for histocompatibility in clinical solid organ transplantation (SOT) focuses on humoral immunity, avoiding donor HLA molecules against which the recipient has pre-existing alloantibodies capable of mediating hyperacute rejection. While this is a practical approach based on clinically-available information, it does not address the inherent risks of T cell alloreactivity, which is a significant contributor to allograft rejection and requires life-long immunosuppression. In this proposal, we will leverage sequencing technologies and approaches adapted from immuno-oncology to identify HLA allele-specific factors in solid organ transplant donors and recipients driving T cell alloimmune responses. Here we propose a new method, Computational Histocompatibility Assessment for Rejection by T cells (CHART) that adopts measures employed for predicting tumor immunogenicity and adapts them for prediction of T cell alloreactivity and rejection risk in SOT. Specifically, CHART will include functionality to perform variant calling from donor whole exome sequencing data and and annotate variants according to abundance, binding to HLA and T cell cross reactivity using measures already employed for neoantigen prioritization. CHART will further predict sample level T cell alloreactivity while accounting for direct (donor peptides presented by donor HLA) versus indirect (donor peptides presented by recipient HLA) modes of recognition, an aspect unique to transplant. We will validate and refine CHART using high resolution HLA typing and molecular profiling data from 20 healthy blood donors and 400 heart transplant recipient-donor pairs with blood and tissue samples available and associated extensive clinical laboratory and clinical outcomes data. The predictive capability of CHART will be tested in an independent cohort of 100 heart transplant donor/recipient pairs. We expect that this will yield significant new insight into HLA biology with information about HLA-allele-specific capability of presenting alloantigens, and potentially result in a novel bioinformatic tool for improved assessment of histocompatibility and evaluating clinical risk in SOT, enabling precision medicine approaches for personalized immunosuppression.